Elucidating Skeletal Muscle Satellite Cell:Microvessel Interactions in Diabetic Muscle

PROJECT SUMMARY
Skeletal muscle dysfunction contributes significantly to the many sequelae of Type 2 Diabetes (T2D). Although
the majority of mechanistic studies directed towards describing diabetic skeletal muscle dysfunction focus on a
single cell type, it is more prudent to investigate the mechanistic interaction linking different types of cells. For
example, the maintenance of skeletal muscle homeostasis in vivo is a coordinated interaction between the
myogenic cells and the vasculature. Satellite cells from myopathic muscle have been shown to have a diminished
effect on angiogenesis, so it is reasonable to speculate that satellite cells from diabetic muscle also have a
weakened ability to maintain vessel function. An understanding of the coordinated interaction between satellite
cells and the vasculature requires an understanding of the mechanisms that regulate satellite cell-mediated
effects on angiogenesis. The overall objective of this application is to elucidate the satellite-cell mediated
mechanisms that contribute to diabetic skeletal muscle dysfunction. The central hypothesis is that satellite cells
derived from diabetic muscle exhibit changes in their exosomes that are manifested as an impaired ability to
promote angiogenesis. The completion of the overall objective for this project will be accomplished by pursuing
three specific aims: (1) Identify the satellite cell-dependent mechanisms that contribute to impaired angiogenesis
in diabetic muscle; (2) Elucidate the role of SIRT1 in mediating satellite cell-dependent mechanisms in diabetic
muscle; and, (3) Determine the mechanisms that cause diminished satellite cell-dependent activity in diabetic
muscle after ischemia-reperfusion (I/R) injury. The outcome of these three separate, but related, specific aims
will be the determination of the mechanisms that control the ability of satellite cells to affect angiogenesis in
diabetic muscle, including during repair after injury.

Public health relevance
PROJECT NARRATIVE Skeletal muscle dysfunction is a major contributor to the negative consequences of Type 2 diabetes. The mechanisms that are responsible for the coordinated interaction between myogenic cells and vascular cells in diabetic skeletal muscle are not understood. The goal of this project is to gain insight into the mechanisms that affect the ability of satellite cells (stem cells resident in muscle) to influence vessel growth in diabetic muscle to enable a more effective development of therapies to treat it.